A Novel Handheld Three-Dimensional Camera for Wound Healing Monitoring

[unreadable] DESCRIPTION (provided by applicant): We propose this Phase II SBIR program to further capitalize on the very promising results from our Phase I effort to develop a novel, handheld three-dimensional (3D) camera able to perform objective, quantitative, and true 3D measurements of the size, shape, volume, color, and healing status of wounds. Accurate measurement of wound healing enables clinicians to assess, document, improve, and individualize the treatment plan given to each wound patient. In current wound care practices, clinicians often visually inspect the wound to evaluate the healing status. This is not an optimal practice because human vision lacks precision and consistency, and quantifying slow or subtle changes is very difficult. As a result, an instrument that quantifies both skin color and geometric shape variations would be particularly useful in helping clinicians assess healing status and judge the effect of hyperemia, hematoma, local inflammation, secondary infection, and tissue necrosis. Our handheld 3D camera developed under this SBIR program will prove itself to have several unique advantages over traditional methods for monitoring wound care, to include: [unreadable] Non-contact measurement: No risk of contaminating the wound site or disturbing the recovering tissue. Fast and easy to use: Acquires a single image in a fraction of a second and automatically merges multiple 3D images into a complete 3D model of the wound in real time; suitable for both hospital and homecare/telemedicine applications. High Accuracy: Sub-millimeter accuracy with optimal depth of field to ensure that changes suggestive of healing are captured precisely and with minimal artifact. Quantitative measurements: Both 2D color and 3D shape provide quantitative digital measurements of wound parameters such as area size, volume, length, depth, surface roughness, and its profile. Handheld device: Not only is it a handy portable instrument, it also provides a unique ability to measure wounds that extend around limbs and that are not fully visible from a single position. [unreadable] Reasonable cost for mass commercial market: The proposed handheld 3D camera design leads to inexpensive production. Our targeted price for such a system in mass production is under $1,000. The proposed handheld 3D camera product, if successful, is expected to have tremendous market potential in clinical, homecare, and telemedicine applications. [unreadable] [unreadable] [unreadable]